Identifying individual-specific gait signatures for stroke rehabilitation

PROJECT SUMMARY/ABSTRACT
Stroke gait deficits are complex and marked by adverse effects on kinematics, kinetics, gait symmetry, and inter-
and intra- limb joint coordination across different phases of the gait cycle. One intervention simply cannot target
the high inter-individual variability of deficits observed in post-stroke gait. Approximately 2/3 of stroke survivors
have persistent gait impairments despite being discharged from rehabilitation, and one reason could be the lack
of tailored rehabilitation approaches to address their individual-specific impairments. The development of tailored
rehabilitation approaches, however, is limited by the lack of robust metrics to identify and analyze individual-
specific differences in gait. The objective of this work is to develop a sensitive, data-driven, consistent
characterization of gait using continuous, multi-joint gait dynamics. The dynamics of gait will be extracted from
measured kinematics (joint angles) and used to develop individual-specific gait characterizations, which we
coined the ‘gait signature.’ We will use these gait signatures to probe the mechanisms underlying stroke gait
impairment using rehabilitation techniques, specifically Fast functional electrical stimulation (FastFES). FastFES
is a gait rehabilitation intervention that targets ankle dorsiflexor muscles to address foot drop, and ankle
plantarflexor muscles to improve ankle torque at push-off. The literature suggests that response to FastFES
depends on the precise alignment between a specific muscle coordination deficit and the gait rehabilitation
modality. This suggests that knowledge of an individual’s specific gait impairment before rehabilitation can
predict their response to therapy. Since FastFES is known to target ankle deficits related to ankle push-off, I will
probe this theory and evaluate whether gait signatures can encode ankle push-off corrections in response to a
single session exposure to FastFES. I predict that stroke individuals with ankle-related push-off deficits will show
the greatest response or change in their gait signature towards normative (able-bodied) gait. Preliminary findings
show that gait signatures accurately discriminate between different stroke individuals. A noteworthy finding is
that our gait signatures do not appear to cluster according to walking speed, leading to our hypothesis that gait
signatures distinguish individual-specific differences in stroke gait corresponding to what we know about
heterogeneity in stroke gait impairments. We aim to determine the functional biomechanical relevance of various
clusters of gait signatures, and we will determine whether FastFES targets a specific cluster of individuals
depending on the biomechanical features, characteristics, or deficits that they have. Furthermore, we will
determine whether gait signatures before FastFES exposure can predict whether stroke-survivor will be a
potential responder to FastFES. If successful, gait signatures will prove to be a robust marker of specific gait
impairments and have important implications for the development of future tailored rehabilitation strategies for
stroke survivors.

Public health relevance
PROJECT NARRATIVE Advancing current rehabilitation approaches is limited by an inability to robustly identify individual-specific differences in gait impairments. In this project, we aim to develop a sensitive, data-driven, consistent tool using continuous, multi-joint gait dynamics to characterize individual-specific differences in stroke gait and evaluate individuals’ potential to improve their ankle push-off with exposure to a single session of functional electrical stimulation (FES) delivered during fast walking (FastFES). Understanding individual-specific gait impairments is necessary for the development of tailored rehabilitation approaches to potentially correct the high variation of gait impairments amongst stroke survivors.